Research Management & Experimental Tools Resources

The Research Management & Experimental Tools (RMET) core addresses three critical goals: i. increase efficiency by centralizing resources frequently duplicated across laboratories; ii. augment innovation by combining best practices across laboratories; and iii. accelerate translation by developing common platforms across research groups ranging from the basic to the applied. These goals will be addressed through three specific aims: 1. Develop a central human subject management tool. A secure web-based application will be developed to support all aspects of recruitment and scheduling. 2. Develop a set of core tools forgathering data across multiple experimental domains. A common, open source, platform-independent experimental software platform will be made available to support common tests across laboratories. 3. Develop a large-scale database for project data. A secure, robust relational database will be developed to allow co-registration of demographic data and behavioral data from both the screener developed by Core 1 (Human Subject Recruitment & Management) as well as additional tests used across laboratories. The human subjects management system will provide a secure way to address common recruitment needs through shared resources. Leveraging experience across laboratories will allows us to develop a high quality set of experimental tools that can be shared with the entire research community. Both of these computational tools, coupled with a large-scale database for project data, will provide a technical infrastructure that can facilitate synergistic research across a wide variety of laboratories.

Public health relevance
RELEVANCE (See instructions): By supporting common efforts in subject recruitment and data acquisition, The Research Management and Experimental Tools core will enable synergistic interactions between Northwestern University laboratories conducting research in core mission areas of the NIDCD.